Multimodal Single-molecule Analysis of DNA Interrogation by Cas9 and Cas12a: Examining the relationship between mismatches, DNA supercoiling, and conformational dynamics

Project Summary/Abstract:
Clustered regularly interspaced short palindromic repeats (CRISPR) and CRIPSR associated (Cas) proteins
are components of a bacterial immune system with memory. Cas proteins acquire segments of the genomes
of invading pathogens and place them in the CRISPR array. Upon reinfection, Cas9 or Cas12a are mobilized
and loaded with guide RNAs transcribed from the CRISPR array. They then cleave invading DNA strands that
contain sequences matching the guide RNA after the creation of a 20-base pair RNA-DNA heteroduplex called
an R-loop. R-loop formation initiates a complex set of conformational shifts in both enzymes, with each
proceeding through distinct checkpoints on the pathway to cleavage competency. Importantly, these
conformational shifts differ between the two enzymes, indicating mechanistic differences. The programmability
and specificity imparted by R-loop induced cleavage make Cas9 and Cas12a excellent biophysical tools.
However, both enzymes can bind to and cleave sites that possess mismatches in the R-loop, leading to
potentially hazardous off-target activity. A full understanding of the effect of mismatches and target DNA
topology on R-loop formation and cleavage is needed to optimize usage and engineering of Cas9 and Cas12a.
DNA in cells is globally underwound and locally under constant flux to due processes that mechanically deform
DNA. In this proposal, high-resolution single-molecule methods developed in the Bryant lab will be used to
observe Cas9/Cas12a R-loop formation and conformational changes simultaneously on supercoiled DNA.
Recently, these methods were used to develop a model for Cas9 R-loop formation in which R-loop mismatches
and DNA supercoiling alter the shape of the Cas9 R-loop formation energy landscape. The resolution of the
methods allowed identification of a discrete R-loop intermediate. Currently, a similar model is being produced
for Cas12a, which also has a discrete R-loop intermediate. The central hypothesis of this proposal is that
R-loop mismatches and DNA supercoiling modulate kinetic transitions between Cas9/Cas12a R-loop
and conformational checkpoints. In aim 1, Cas9 FRET and R-loop states will be simultaneously observed,
correlating conformational and R-loop checkpoints. This will require technical updates to microscopy methods
to increase resolution. Preliminary experiments indicate the feasibility of these measurements, showing
coincident R-loop and FRET signals. In aim 2, similar measurements will be performed using Cas12a.
Current data show that Cas12a has different R-loop checkpoints and is highly sensitive to supercoiling. Data
acquired in these aims will build a complete picture describing the effect of R-loop mismatches and DNA
supercoiling on Cas9 and Cas12a activity and specificity. The models developed from these measurements
will reveal links between Cas9/Cas12a mechanistic and specificity differences. This information will assist in
designing mutations and perturbations to minimize off-target activity in experimental and clinical settings.

Public health relevance
Project Narrative: Cas9 and Cas12a are RNA guided endonucleases with high natural specificity, making them promising tools for genetic engineering and the treatment of diseases caused by genetic defects. However, we lack a detailed understanding of the relationship between mismatches and DNA supercoiling and their effect on Cas9/Cas12 conformational checkpoints and specificity. The experiments proposed here will elucidate this relationship, identifying mechanistic differences between Cas9 and Cas12a and providing models with information to aid the design of low-risk experiments and therapeutics.